Redox Control of Seizure-Induced Neuroinflammation.

Inflammation and oxidative stress are two important processes known to occur concurrently in
epilepsy. Neuroinflammation is a well-recognized mediator of acquired epilepsy and a highly
investigated target for therapeutic intervention. Glutathione depletion occurs following insults that
cause epilepsy and its repletion can modify seizures and cognitive impairment. Recent work in
our laboratory has shown that elevation of glutathione can inhibit neuroflammation. The long term
goal of this proposal is to elevate brain glutathione levels in models of acquired epilepsy by a
novel mechanism i.e. direct posttranslational activation of its rate-limiting synthetic enzyme, -
glutamyl cysteine ligase. The goal of this proposal is to test the hypothesis that increased de novo
synthesis of glutathione decreases neuroinflammation, seizures and/or cognitive dysfunction.
Aim. 1 will test select compounds for their ability to increase glutathione, inhibit neuroinflammation
and neuronal excitability in vitro. Aim 2 will determine if compounds capable of elevating
glutathione inhibit seizures, epilepsy and/or cognitive dysfunction. These studies can identify a
novel mechanism of reducing neuroinflammation in acquired epilepsy and suggest redox-based
compounds for the treatment of epilepsy and associated comorbidities.

Public health relevance
Neuroinflammation is a critical therapeutic target for acquired epilepsy; novel ways to reduce it with fewer adverse effects are much needed. The proposal explores a novel mechanism of elevating brain glutathione to decrease neuroinflammation, epilepsy and cognitive dysfunction. The studies can provide a novel redox based mechanism to decrease neuroinflammation in epilepsy.